The Role of CREBRF on Hypothalamic Function

Obesity is escalating at an alarming rate and is a major contributor to associated to multiple serious health
problems such as Type 2 diabetes. Interesting, a missense variant in humans was identified in the poorly
understood gene CREBRF to increase BMI while protecting from developing diabetes. CREBRF is a
transcriptional co-regulator that is expressed centrally and within the hypothalamus, whose neurons integrate
information from other brain regions as well as the periphery to control many homeostatic functions such as food
intake and stress responses. Furthermore, loss of CREBRF in mice impacts hypothalamic output observed by a
reduction in body weight, glucocorticoid levels after an acute stressor, and anxiety-like behaviors. Therefore, the
overall objective of this proposal is to determine how CREBRF impacts hypothalamic function by determining its
localization and recruitment to the genome in a brain region critical for stress responses. Our central hypothesis
is that CREBRF functions as a transcriptional co-regulator to regulate gene expression, ultimately influencing
metabolic and behavioral outcomes. The central hypothesis will be tested using the novel CREBRF3xFLAG mouse
model and our expertise in neuroanatomy, genome-wide analysis, and behavioral phenotyping to achieve the
following sub-aims: 1.) to determine the impact of CREBRF on the transcriptional response to acute stress within
the hypothalamus, 2.) to systematically characterize hypothalamic CREBRF by determining its regulation and
localization during acute stress, and 3.) to perform baseline phenotyping for this novel CREBRF3xFLAG global
mouse model. Using antibodies to detect the 3x-FLAG tag, we expect to gain a substantial amount of information
about CREBRF while ensuring this small tag does not impact CREBRF function and interpretation of our results.
This research will provide deep understanding for a relatively unknown gene and advance our understanding for
how CREBRF impacts physiology and behavior. These Sub-Aims will complement ongoing K01 research and
expand our research capabilities to further understand the role of CREBRF on hypothalamic function, ultimately
impacting output. Support provided by this R03 Award will allow Dr. Frahm to continue to build her independent
research program by generating preliminary data for a competitive R01 grant submission.

Public health relevance
PROJECT NARRATIVE This research will use our expertise in neuroanatomy, behavioral phenotyping, and genome-wide analysis to examine a recently generated CREBRF3xFLAG mouse model to examine hypothalamic CREBRF. This research is relevant to the public health because it will determine the function of a poorly-characterized gene that impacts glucocorticoid signaling, anxiety-like behaviors, body weight, and diabetes-risk. The proposed research is relevant to the NIH mission because it will promote the understanding of fundamental mechanisms contributing to obesity, thereby promoting disease prevention and treatment.